Delivering Food Resources & Kitchen Skills (FoRKS) to Adults with Food Insecurity and Hypertension: An RCT

ABSTRACT
Food insecurity, defined by the United Nations as inconsistent access to a sufficient quantity of affordable,
nutritious food, is a prevalent SDOH among safety-net primary care patients. Among adults with food
insecurity, conditions like hypertension (HTN) and type 2 diabetes (DM2) are as much as two times more
prevalent. Widely available chronic disease self-management education and support (SMES) programs place
much emphasis on nutrition education but do not significantly address access to affordable, nutritious food or
meals. Notably, simulations have shown that medically-tailored meals for food-insecure adults could be as
cost-effective as some commonly prescribed medications.
Drawing upon our knowledge of systems engineering and user-centered design, our team created and
successfully piloted a novel, dietitian-led sociotechnical intervention called FoRKS: Food Resources & Kitchen
Skills. Safety-net primary care patient-participants (N=20 across two pilots) received essential home cooking
tools, home delivered lower sodium, lower-carbohydrate Mediterranean-style meals and ingredients, and twice-
weekly hands-on home cooking classes. Mean attendance was 87% and mean satisfaction was 4.7/5.0 for
delivered foods and 4.9/5.0 for hands-on cooking class. Webex videoconference classes allowed participants
to learn and cook together in a socially supportive “space” from their own home kitchen.
We here propose a randomized controlled trial to evaluate FoRKS versus enhanced usual care (EUC). Safety-
net primary care patients aged 35 years or over with food insecurity and systolic blood pressure ≥120 mm Hg
(~40% will also have DM2) will be invited, consented, assessed, and randomized. EUC consists of SDOH
screening, referrals to food pantries, and assistance enrolling in food programs (e.g., SNAP). EUC also
consists of our CDC-approved 5-week SMES program. Those randomized to FoRKS will, in addition to EUC,
receive home-delivered meals and ingredient kits, and twice-weekly Webex cooking classes to week 16. In
week 17, participants will transition from FoRKS-delivered foods to shopping for affordable, nutritious foods.
FoRKS classes will continue in order to maintain learning and social support that may be critical to longer-term
engagement and self-efficacy for obtaining and preparing nutritious food.
The primary hypothesis is that, relative to EUC, FoRKS participants will experience lower mean systolic blood
pressure immediately post-intervention (16 weeks post-baseline). Maintenance to 24-weeks post-baseline will
also be assessed. Food security, nutrition, and HbA1c will also be evaluated as will cost-effectiveness and
behavioral mechanisms such as learning engagement, self-efficacy, and food resource management skills.

Public health relevance
NARRATIVE This project will test the effect of a home delivered foods and kitchen skills (FoRKS) intervention among adult safety-net primary care patients who report food insecurity and have hypertension. Sixteen and 24-week blood pressure will be compared between participants randomized to FoRKS vs enhanced usual care. Additional outcomes include learning engagement, kitchen confidence and skills, and nutrition and food security.